Resource Section

PROJECT SUMMARY: RESOURCE SECTION
The role of the Resource Section will be to provide necessary animal infrastructure by maintaining live colonies
of relevant rat and mice strains/stocks to supply animals and/or materials from these animals to the Genome
Editing and Biological Effects Testing Section of the MU Rodent Testing Center for Somatic Cell Genome Editing
and to any other investigators who want to take advantage of the Testing Center’s activities and services. Our
group has longstanding expertise in all aspects of rodent importation, animal model characterization, breeding
and world-wide distribution of live animals and animal-related materials and importantly, we are equally familiar
with both mice and rats. We are experts at the management of rodent disease models regardless of their disease
phenotype. We have access to a state-of-the-art vivarium, an established comprehensive animal colony
management system and tested protocols for all aspects of model acquisition, animal care, model
characterization and live animal/animal material distribution. In addition to oversight of animal
breeding/production colonies and supplying animals/embryos/materials for in vivo testing, the Resource Section
will be responsible for ensuring that all rodent strains/stocks and associated information are readily available to
users, strains/stocks are cryoarchived if needed and deposited to the NIH-funded national rodent repositories as
appropriate. The latter will be greatly facilitated by the fact that both the MU Mouse Resource and Research
Center (MMRRC) and Rat Resource and Research Center (RRRC) are on-site at the University of Missouri and
the members of our group are affiliated with both these repositories. Because of our extensive experience,
outstanding facilities, and equal familiarity with all aspects of working with both mice and rats, we are uniquely
suited to support the rodent in vivo testing needs not only of the Genome Editing and Biological Effects Testing
Section of the MU Rodent Testing Center for Somatic Cell Genome Editing but for any other investigators who
want to take advantage of the Testing Center’s activities and services on a fee-for-service basis.
1